Precision Genome Engineering

ABSTRACT
Support is requested for a Keystone Symposia conference entitled Precision Genome Engineering, organized
by Drs. Jacob E. Corn, Kathy K. Niakan and Cecilia Cotta-Ramusino. The conference will be held in Whistler,
British Columbia, Canada from February 13-17, 2022.
Precision genome engineering has completely revolutionized biological research and is making
groundbreaking inroads to therapies. Progress is rapid and the ability for researchers to meet and network is
essential in order to stay updated with the latest advances in the field. This conference will focus on new
fundamental CRISPR-Cas biology, creation of new genome engineering tools (both CRISPR-Cas and
otherwise), provide updates on new biological applications, and discuss the latest advances on applications
moving towards market, such as therapies and agricultural developments. The Keystone Symposia
conference on CRISPR has been a benchmark of the field and draws large audiences. The continued
development of creative new tools and further progress towards real-world application will be a big attraction
for participants. This conference will also include workshops and panels on ethical questions that will enrich
the scientific program. Finally, this meeting will be held jointly with the Keystone Symposia conference
Emerging Cellular Therapies. This is an ideal pairing as genome engineering has become de rigueur in this
arena. Genome engineer attendees will benefit by learning pain points and missing pieces in the field of
cellular therapy, and cell therapy attendees will benefit by hearing about the latest breakthroughs in the fast-
paced field of genome engineering.

Public health relevance
PROJECT NARRATIVE The ease of use of the CRISPR-Cas9 genome editing tool has allowed a rapid expansion of both gene editing in therapeutic applications as well as enabling a range of discovery tools for functional genomic screens, creation of new cellular models and molecular recording approaches. This has led to an expansion of novel technologies to control gene expression and alter genomes, but the challenge now is to understand the strengths and limitations of each of these tools and how best to deliver them efficiently and precisely to the cell and tissue of interest. By bringing together key innovators in all these subjects, including functional genomic approaches to identify new therapeutic target and CRISPR-base lineage tracing to explore disease processes, this meeting will be a key catalyst to address these critical issues.